FACTORS AFFECTING INTERINDIVIDUAL RESPONSIVENESS TO DRUGS

To test the hypothesis that elderly subjects that have genetic deficiency in one route of metabolism are at particular risk for concentration-dependent adverse effects due to a further age-dependent loss of drug metabolizing ability in an alternative pathway.